Viral Testing Core

PROJECT SUMMARY - Core B: Viral Testing Core
Genetically characterized rhesus macaques that are free of endemic viral pathogens have become the
premier animal model for HIV/AIDS research, including studies on HIV pathogenesis, AIDS-related
opportunistic infections, as well as the development of HIV treatments and vaccines. The establishment of
specific pathogen-free (SPF) colonies also serves to protect animal caretakers from zoonotic diseases and
improves overall animal health. However, the successful derivation and maintenance of SPF colonies is
challenging and requires strict surveillance regimens over long periods of time. Therefore, the overall aim of
the Viral Testing Core is to provide appropriate pathogen surveillance and implement state-of-the-art testing
services, in order to maintain our breeding colony is specific pathogen free and provide surveillance and
antibiotic stewardship interventions for common pathogens affecting the health of the colony. To do this, we
will use proven virus screening algorithms combined with an expanding arsenal of screening assays, rapid
multiplex molecular panel testing, and antibiotic stewardship interventions. A central strategy to achieve this
will be the implementation of a multiplexed protein microarray assay platform for routine colony screening,
which we have developed and validated at our Center, and the rapid multiplex PCR testing which is being
validated for NHPs at our Center.